Gene Delivery Nanoparticles to Treat Glioblastoma

There is a need to create new biotechnology to safely and effectively deliver miRNA to target cells
of interest in the brain. We propose to develop enhanced polymeric nanoparticles designed to be
stable extracellularly and bioreducible intracellularly, to enable safe and effective delivery of
miRNA. We will validate these particles in models of brain cancer as it is a deadly disease that
is in critical need of new therapies. In particular, we will evaluate treatment of human
glioblastoma in orthotopic models compared to the standard of care. Polymer structures will be
synthesized and utilized to fabricate non-viral nanoparticles for delivery to multiple brain cell
types including healthy cells and cancer cells. Nanoparticle formulations will be developed that
remain stable in cerebrospinal fluid (CSF) and that can spread throughout the brain following
administration by convection-enhanced delivery (CED). We will investigate novel miRNA drugs
capable of overcoming known drug and radiation resistances by targeting tumor-propagating brain
cancer stem cells (BCSCs). Novel miRNA combinations will be evaluated in vitro and in vivo. The
nanoparticles will be tracked to evaluate their intracellular and extracellular delivery and cell
specificity. Transport and safety through normal and tumor- bearing rodent brains following CED
will be analyzed. Leading nanoparticles will be evaluated in an orthotopic model for human
glioblastoma using molecular and cell biological endpoints and anti-tumor efficacy will be compared
to the standard of care as well as in combination with the standard of care. We will create an
innovative technology for miRNA delivery and validate it in models of brain cancer.

Public health relevance
The purpose of this research proposal is to develop a new platform nanobiotechnology to deliver microRNA molecules to cells to treat human diseases. The technology will be validated by delivering specific microRNA molecules to treat human brain cancer in vitro and in vivo in rodent models.